Characterize Emerging HIV Strains from Blood Donors and Patients

The purpose of this agreement is to characterize emerging HIV strains from blood donors and patients and to determine viral tropism based on co-receptor usage of strains.